Multidimensional analytical and computational approach to determine diastereomer compositions in oligonucleotide drug products

PROJECT ABSTRACT
Synthetic (short) oligonucleotides are an exciting class of therapeutics to treat and prevent a wide variety of
diseases, including diseases where traditional drug development efforts have failed. In contrast to native nucleic
acids, which are prepared enzymatically, synthetic oligonucleotide drugs are prepared chemically via solid-phase
chemical synthesis. Solid-phase chemical synthesis provides an advantageous platform for introducing chemical
modifications during drug development to overcome the poor pharmacological properties of native nucleic acids.
A common chemical modification for oligonucleotide drugs involves the replacement of one oxygen in the natural
phosphodiester (PO) linkage with a sulfur creating a phosphorothioate (PS) linkage. The PS linkage enhances
pharmacology properties by increasing nuclease resistance and facilitating protein binding. The PS modification
is routinely used in antisense oligonucleotide (ASO) therapeutics that are a prevalent platform for drug discovery
with several ASOs gaining United States Food and Drug Administration (FDA) approval. The consequence of
chemically replacing the PO linkage with a PS linkage is the creation of a chiral center at the phosphorous atom.
This leads to the PS center having two stereochemical configurations. The number of potential PS diastereomers
is 2n where n is the number of PS linkages in the oligonucleotide. For a 20-mer oligonucleotide which has 19 PS
linkages this equates to 524,288 potential stereoisomers. Despite the increasing popularity of ASO drugs, there
is a pressing need to develop high-resolution analytical methods that can comprehensively characterize the
diastereomer composition in oligonucleotides for quality control purposes in manufacturing and generic drug
development. Consequently, the purpose of this proposal is to develop new and innovative analytical methods
for analyzing the diastereomer composition in ASO drugs. We will use TEGSEDI as our model ASO drug product.
Our proposal will determine whether and how the manufacturing process may affect the diastereomeric
distributions in the drug product. We intend to successfully accomplish these objectives by developing a
multidimensional analytical approach that computationally integrates state-of-the-art liquid chromatography,
mass spectrometry (MS) and nuclear magnetic resonance (NMR) spectroscopy. Our experimental approach will
include in-house chemical synthesis of inotersen (generic name for TEGSEDI) and short chain fragments to
investigate the effect chemical synthesis (i.e., manufacturing) has on the stereochemical outcome in PS linkage
formation. We will use data science including multivariate analysis and clustering to assess the diastereomer
composition and apply machine learning techniques to predict the diastereomer compositions of TEGSEDI and
our in-house prepared inotersen. Our developed methods will be directly transferable to other synthetic
oligonucleotides and will greatly facilitate the development and assessment of generic oligonucleotide drug
products.

Public health relevance
PROJECT NARRATIVE Synthetic oligonucleotides are an emerging class of biopharmaceuticals to treat various diseases, including neurological disorders, cancer, cardiovascular and metabolic diseases. This project will develop new and innovative methods to determine the phosphorothiate diastereomer composition in oligonucleotide drugs. The developed methods will greatly enhance quality control of oligonucleotide manufacturing and accelerate development of generic oligonucleotide drug products.